Health Communications (HC)

PROJECT SUMMARY/ABSTRACT (HEALTH COMMUNICATIONS SHARED RESOURCE)
Patient-centered communication tailored to the specific needs of individuals, patients, and family members is an
essential part of high-quality cancer care. The Health Communications Shared Resource (HC-SR) enables Rogel
Cancer Center (Rogel) members to conduct state-of-the-science research using innovative communication
channels and technologies in diverse settings across the continuum of cancer care. HC-SR is comprised of an
interdisciplinary team of behavioral and communication scientists, designers and graphic artists, and
technologists and programmers that work together to create user-centered interventions. The aims of the HC-
SR are to i) enable Rogel members to conduct state-of-the-science health communications research across the
continuum of cancer care; ii) apply health communication science to advanced patient and family member
engagement with cancer research and the practice of precision oncology; iii) apply health communication science
and strategies to engage community partners in advancing cancer research and addressing cancer-related
health disparities in our Rogel catchment area. In this past cycle, HC-SR supported high impact research and
community engagement by Rogel members including i) publication of groundbreaking clinical trial results
demonstrating the efficacy of tailored health communications to improve cancer-related treatment decision-
making and symptom management; ii) receipt of three major multi-investigator U awards from NCI led by Rogel
members; and iii) support for major COE initiatives in our catchment area (e.g., addressing the impact of the
COVID-19 pandemic on cancer screening among medically underserved groups).